Two-Color Near-Infrared Fluorescence Guided Surgery Tools Enabling Simultaneous Cancer Margin and Nerve Visualization during Head and Neck Squamous Cell Carcinoma Resection

PROJECT SUMMARY
Head and neck squamous cell carcinoma (HNSCC) is the sixth highest incidence cancer worldwide, with
>650,000 cases annually. Surgery is a primary treatment option for HNSCC, during which surgeons face two
main goals: 1) complete cancer resection and 2) preservation of normal tissue structures such as muscle, blood
vessels, and nerves to ensure post-surgical quality of life. Unfortunately, these goals are not synergistic, where
complete cancer resection is often limited by efforts to preserve normal tissue and reduce life altering
comorbidities. In fact, positive surgical margins are found in 20-30% of patients, and nerve damage represents
a major surgical comorbidity, with 5-30% of patients experiencing lasting pain or loss of function. Currently, no
technology exists to enhance intraoperative cancer and nerve recognition. Thus, technology to provide
direct visualization of cancer margins and nerves simultaneously in real time would greatly improve surgical
outcomes and reduce comorbidities for HNSCC patients. Fluorescence Guided Surgery (FGS) has successfully
integrated into clinical medicine, providing surgeons real-time visualization of important tissues and complex
anatomy. Using compact and high-resolution FGS imaging systems, which operate almost exclusively in the
near-infrared (NIR, 700-900 nm), surgeons can image targeted fluorescent probes with high contrast at up to
centimeter depths. NIR Nerve-specific and HNSCC-targeted probes under development would together provide
an integrated FGS tool for HNSCC resection. Several peptide-based FGS imaging probes have demonstrated
efficacy in identifying tumor margins and are currently in phase II and III clinical trials, including those targeting
epidermal growth factor receptor (EGFR), matrix metalloprotease (MMP), and integrins. We have developed
first-in-class NIR nerve-specific fluorescent small-molecule probes that demonstrate high nerve signal to all
background tissues (e.g., muscle, adipose, vasculature, fascia, etc.) following intravenous administration in
rodents and swine. Importantly, the tumor-targeting FGS probes utilize fluorescent reporters centered at 800-nm
wavelengths, while our nerve-specific probes fluoresce at 700-nm wavelengths, providing spectrally distinct
tissue detection and compatibility with existing two-color FGS systems. The combination of these two
promising technologies would provide a comprehensive, innovative solution to enhance cancer control
and nerve sparing during HNSCC resection. This study’s immediate milestones will include (1)
characterization of our lead NIR nerve-specific fluorophore for head and neck procedures, (2) quantification of
tumor- and nerve-specific FGS probe co-administration performance including cross-talk, and (3) assessment of
this technology using a clinical two-color FGS system. This work will result in the first comprehensive FGS tool
for cancer resection and nerve sparing during head and neck procedures. The proposed development will
provide important proof-of-concept for further development and partnership. In Phase II, the first two-color tumor
and nerve targeted FGS studies will be completed in patients undergoing HNSCC resection.

Public health relevance
PROJECT NARRATIVE Surgery is a primary treatment option for head and neck cancer patients, however, incomplete tumor resection and nerve damage plague surgical outcomes, reducing cancer-free survival rates and causing lasting pain and loss of function. Currently, no clinically approved technology exists to enhance intraoperative cancer or nerve recognition and surgeons rely solely on white light visualization and palpation. The proposed aims will develop a combination of robust peptide-based tumor-targeted fluorescent probes and novel nerve-specific fluorophores that provide enhanced direct visualization of tumor margins and nerves to enhance cancer control and nerve sparing during head and neck cancer resection.